UNC Center for AIDS Research Core F Biostatistics

PROJECT SUMMARY/ABSTRACT – BIOSTATISTICS CORE (CORE F)
The comprehensive, long-term objectives of the Biostatistics Core are to provide state-of-the-art statistical
support for HIV/AIDS-related research of the UNC CFAR. The specific aims include: (1) providing a broad
spectrum of collaborative biostatistical services; (2) developing, implementing, and disseminating innovative
statistical methods for HIV research; (3) facilitating intra-CFAR research, fostering inter-CFAR collaborations,
and supporting NIH HIV research networks and international HIV research; (4) supporting Scientific Working
Groups (SWG) and Research Interest Groups (RIG), training, and mentoring; (5) conducting strategic planning,
evaluation, and dissemination/outreach. To achieve these aims, members of the Biostatistics Core proactively
engage with UNC CFAR investigators to identify and deliver services essential for highly productive design,
conduct, analysis and publication of HIV research. The Core contributes to the framing of hypotheses,
development of study designs, preparation of grant applications, selection of appropriate statistical methods, and
delivery of statistical analyses. Developmental Awardees, Early Stage Investigators, and experienced
investigators new to HIV research receive highest priority for Core services. The Core also develops and
implements innovative statistical methodologies as needed for CFAR studies. Additionally, the Core provides
training and education to the CFAR research community to equip investigators with traditional as well as
innovative statistical methods needed to conduct HIV related research. Strong institutional support from the UNC
Department of Biostatistics allows the Core to take full advantage of existing infrastructure, resources and
contacts with faculty renowned for their expertise in specialized fields of statistics. Leadership and strategic
planning of the Core will be guided by consultation with the CFAR Executive Committee, surveys of the CFAR
membership, an Internal Advisory Board, an External Advisory Board, and through participation in CFAR
retreats.